GUANIDINIUM DERIVATIVES FOR THE TREATMENT OF OCULAR PAIN

PROJECT SUMMARY The absence of safe and effective strategies for the management of ocular pain is motivating the development of a novel topical drug suitable for patient self-administration. Conventional local anesthetics, such as proparacaine, inhibit voltage-gated Na+ ion channels (NaV) and are highly effective for the management of ocular pain in acute, in-office settings. However, these agents are short acting and toxic to the corneal surface, which prevents their use beyond a few administrations. SiteOne Therapeutics has discovered a chemical series of novel, exquisitely selective inhibitors of human NaV1.7, a subtype implicated in the transmission of pain signals by human genetics. These compounds exhibit excellent analgesic effects when administered systemically. Topical ocular administration is well tolerated and leads to good intraocular exposure. The goal of this phase II grant is to fund preclinical studies including candidate selection, formulation development, and early IND-enabling studies.

Public health relevance
PROJECT NARRATIVE Ocular pain is the single most common reason for a visit to an ophthalmologist. Despite the high prevalence of this condition, currently no drug is available to effectively manage it. Existing local anesthetics, such as proparacaine, are toxic to the corneal surface and suitable only for in-office administration. We aim to develop a safe, effective, long-acting topical therapy for ocular pain and discomfort, which is suitable for patient self- administration.